Core E: Clinical Translation Core

PROJECT SUMMARY/ABSTRACT
The Clinical Translation Core (CTC) supports the UNC RTCC by providing access to human
biospecimens, clinical research expertise (including biostatistics, bioinformatics, trial design, and
regulatory assistance) and specialized clinical research outcome measures. These functions
have supported more than 40 investigators and the conduct of many research studies. In the
current application, the CTC focus will shift its focus to research aimed at defining the
pathophysiologic basis of GI symptoms and complications in people with cystic fibrosis. Toward
this end, new partnerships with experts in GI biology and disease have been formed to meet
these scientific challenges. Strategies that maximize capture of precious human samples during
both clinically indicated and research procedures will be implemented. Ongoing biostatistical
and study design support will be provided, while also continuing to maintain previously
developed core functions that support respiratory research.